The original concepts for these tasks evolved during the development process. Final designs have been agreed upon to complete these tasks. The additional work will include the delivery of a bubble cha

Alzheimer's disease